Function and regulation of mucosal associated invariant T cells in the lung

Project Summary/Abstract
Asthma remains a serious public health threat with unmet therapeutic needs. The
development of successful therapies relies a more in-depth understanding of the immune
subsets and pathways involved. MAIT cells are innate-like T cells that recognize microbial
riboflavin metabolites presented by MR1 and can function through both TCR dependent and
independent pathways. Interestingly, previous studies indicated an inverse association between
MAIT cells and human asthma. The precise role of MAIT cells in asthma development and
exacerbation, however, remains unknown. Our recently published work and additionally
preliminary data indicate a striking anti-inflammatory role for MAIT cells in allergic airway
inflammation. We hypothesize that a deficiency of MAIT cells in asthma patients contributes to
exacerbated airway inflammatory responses to allergens, and that increasing MAIT cell
numbers may help alleviate allergen-induced airway inflammation and hyperresponsiveness.
Using fresh lung samples from deceased organ donors, we will examine the abundance and
molecular properties of lung-resident MAIT cells in severe asthma patients and control
individuals without lung diseases. We will use MAIT cell deficient mice and adoptive transfer
strategies to interrogate the specific roles of MAIT cells in allergic airway inflammation. Finally,
we will test whether boosting the number of MAIT cells by an engineered probiotic strain can
help alleviate ongoing airway inflammation induced by common allergens.

Public health relevance
Project Summary This project aims at understanding the function and regulation of mucosal associated invariant T cells in allergic airway inflammation. Our work will provide novel insights into the biology of innate-like T cells, and may also inform strategies to combat asthma.